Investigating the Pathological Features of Clonal Hematopoiesis-derived Macrophages

PROJECT SUMMARY
Clonal hematopoiesis of indeterminate potential (CHIP) is an age-associated condition defined by the expansion
of hematopoietic cells that harbor mutations commonly found in leukemia, in the absence of hematological
malignancies or related pathologies. CHIP is highly prevalent in the aging community, with about 10-30% of
individuals over the age of 70 acquiring the condition, and is associated with an increased mortality rate among
the elderly. Surprisingly, this increased mortality rate is largely driven by an elevated risk of atherosclerotic
cardiovascular disease (ASCVD). CHIP carriers have been found to have a 2-fold increased risk of myocardial
infarction, stroke, and heart failure. Murine studies have shown a causal association of CHIP with ASCVD, largely
by upregulating proinflammatory pathways in pathogenic macrophages. Though the use of mouse models has
allowed us to gain insight into important mechanisms involving CHIP, there are aspects of human physiology
that are not captured in a murine system. This study will utilize a tractable, human primary model of functional
CHIP macrophages, along with humanized mouse models to study the pathological features of CHIP-related
atherosclerosis.
The objective of this proposed study is to determine what mechanisms in human cells are important in CHIP-
related ASCVD. The overall hypothesis of this study is that CHIP-related mutations will increase key inflammatory
signaling pathways in human myeloid cells that may not necessarily be conserved in mice, contributing to
exacerbation of cardiovascular disease. The aims addressed in this proposal are: 1) to determine the
transcriptional changes in primary human macrophages under proinflammatory activation, 2) to determine the
mechanisms mediating the protective effect of an IL6R variant for CHIP associated CVD in primary human
macrophages, and 3) to determine phenotypic changes of macrophages in a chronic inflammation model of
clonal hematopoiesis in a humanized murine in vivo system. The use of a primary human macrophage model of
CHIP will bridge the gap in knowledge between what has been observed clinically versus what has been
observed in murine models of CHIP. Work for this proposal may suggest suitable targets for pharmaceutical
intervention.

Public health relevance
PROJECT NARRATIVE As about a tenth of the population over 70 ages, a clonal population of mutated leukocytes, namely clonal hematopoiesis, arises that is typically benign in nature. Studies from our laboratory has shown that the outgrowth of these clonal populations, is linked to a casual role in the development of heart diseases. In our studies, we hope to fill the gap in knowledge by determining the mechanism behind this causal link in primary human models of clonal hematopoiesis.